Patterning and Formation of the Neuromuscular Junction

Project Summary
The long-term goal of our research project is to define mechanisms that govern the development and
maintenance of motor neurons, as well as the formation and maturation of the synaptic connection between
the motor neuron and the skeletal muscle - the neuromuscular junction (NMJ).
The mammalian NMJ is a classic model of cholinergic synapses; it contains all elements of cholinergic
synapses, including the neurotransmitter acetylcholine (ACh) and the ACh receptor (acetylcholine receptor,
AChR), as well as the enzymes responsible for biosynthesis and degradation of ACh, choline acetyltransferase
(ChAT) and acetylcholinesterase (AChE), respectively. We use the NMJ as a model for understanding
synapses as it can provide information pertinent to both peripheral and central synapses. Its relatively simple
structure and easy accessibility make it more amenable to investigation than those of the central nervous
system (CNS). Furthermore, the NMJ has a significant advantage over the CNS because genes can be
deleted separately in the pre verses post-synaptic compartment, thereby facilitating the study of compartment-
specific functions.
This project addresses a fundamental question in the interaction between the nerve and the muscle – how
does muscle signal to the nerve to promote motor neuron survival, and to regulate synapse formation and
maturation? Using targeted gene deletions in mice, we found that muscle activity, mediated through muscle
dihydropyridine receptors (DHPRs) and a newly identified protein, STAC3 (SH3 and cysteine-rich domain-
containing protein 3), plays a key role in regulating motor neurons and the NMJ. Like DHPR, STAC3 is
localized at the T-tubules and is required for excitation contraction coupling in skeletal muscles. Our
preliminary findings open a new avenue of investigation for identifying feedback mechanisms from the muscle
to the nerve, and will provide important insights supporting future development of therapeutic strategies to
prevent motor neuron loss and treat neurodegenerative diseases such as amyotrophic lateral sclerosis (ALS).

Public health relevance
Project Narrative This project aims at defining mechanisms responsible for the formation and maintenance of the neuromuscular junction (NMJ), and the survival of motor neurons. This is important because abnormal formation or function of the NMJ, as well as the loss of motor neuron, is implicated in neurodegenerative diseases such as amyotrophic lateral sclerosis (ALS). Therefore, identifying regulatory mechanisms responsible for structural and functional changes in the NMJ will enable us to improve current treatment strategies for neurodegenerative diseases such as ALS.